DIAGNOSIS OF INBORN ERRORS OF METABOLISM IN INFANTS AND CHILDREN

Specification of the most effective evaluations and exclusion of specific disorders of intermediary metabolism are being sought by testing analyses and performing metabolic challenges. (This is an ongoing study.)